21st Annual South Central Medical Mycology Meeting

Abstract
Funds are being requested to provide partial support for the 21st Annual South Central Medical
Mycology (SCMM) meeting to be held in New Orleans, LA in association with LSU-Health,
Tulane University School of Medicine, and the Medical Mycological Society of the Americas
(MMSA), on November 21-22, 2024. SCMM prides itself on bringing a critical mass of medical
mycology researchers together from the south central region of the United States to share the
latest research being conducted in the various labs, provide opportunities for collaboration, and
promote the development of junior trainees in participating laboratories. The meeting site rotates
between university-centered locations in the south central region where fungal-centric
laboratories are located. Principal Investigators and students/postdocs from ~15 laboratories
usually attend annually (including laboratories in the host city). In total there are upwards of 20
laboratories that have attended one or more of the meetings depending on the location site. A
strong and growing critical mass of medical mycologists have supported this meeting and led to
its longevity and significance over the past 20 years. Although the meeting format has evolved
over the years, the current format has focused on oral presentations by trainees regarding their
most exciting and impactful unpublished data. The small group setting provides a welcoming
environment that has been successful in promoting discussion and constructive feedback for
trainees. Hence, the primary objectives of the meeting are to 1) bring regionally-based medical
mycologists together to share research, initiate collaborations, and provide a venue for trainees
to present their latest work, and 2) promote the development of young/junior scientists as a
mentoring tool to facilitate their transition into academic scientists or their chosen career path.
The funding request is for trainee travel awards (n=10), costs of the venue, and to partially
cover travel costs for the keynote speaker.

Public health relevance
Narrative The South Central Medical Mycology (SCMM) meeting is quite unique in that it is focused primarily on presentations of unpublished work by graduate students and postdoctoral fellows of all levels from laboratories of successful Principal Investigators (PIs) in the region. Hence, the impact and significance of the SCMM meeting has and continues to be high. The 21st Annual SCMM Group meeting will be held in New Orleans, LA at the Chateau LeMoyne Hotel with Louisiana State University Health – New Orleans, Tulane University School of Medicine, and the Medical Mycological Society of the Americas (MMSA) as co-sponsors.